2025 Mycotoxins and Phycotoxins Gordon Research Conference and Gordon Research Seminar

Summary
The 2025 Gordon Research Conference (GRC) on Mycotoxins and Phycotoxins provides an international
forum for the presentation and discussion of emerging research on fungal and algal toxins, their effects on
human and ecosystem health, and the biology and ecology of toxin production. Fungal and algal toxins are
naturally occurring food and water contaminants that adversely affect human and animal health globally, with a
disproportionate impact in developing nations. A multidisciplinary approach is critical in detecting,
understanding, managing and mitigating their health and economic impacts. The 2025 GRC on Mycotoxins
and Phycotoxins will provide a forum for academic, government, and private sector scientists to exchange
ideas on harnessing advances in biology, chemistry, ecology, plant pathology, epidemiology, and risk
assessment to address the problems associated with the occurrence of these natural toxins. The goal of the
conference is to bring together a wide range of outstanding senior scientists and junior investigators (graduate
students, postdoctoral investigators, and early-career scientists), from diverse backgrounds and geography, to
address the task of ensuring the safety of food and water supplies. Interactions between junior and senior
scientists, and across the two areas of expertise, will be strongly promoted in the best tradition of this GRC.
Vigorous discussions, guided by recognized discussion leaders, will be key for identifying new strategies for
dealing with the complex problems presented by biotoxins. Dedicated daily poster sessions and more relaxed
social activities, such as a banquet dinner and traditional soccer and ping-pong matches during afternoon free-
time, will also provide opportunities for fertile cross-disciplinary interactions and the evolution of new
collaborations towards innovation.
The 2025 Gordon Research Seminar (GRS), immediately preceding the GRC, will be organized and led by a
graduate student and postdoctoral researcher. While the 2-day meeting shares common core and diversity
aims with the larger GRC, it is unique in that only junior scientists attend, present their work, and engage in
discussion with their peers. The environment will be welcoming and collegial and will provide an unmatched
opportunity for future researchers to interact. The GRS leaders have also designed career mentoring into the
meeting by inviting six mentors who are established in their disciplines. Additionally, two leading junior
investigators from this seminar will be chosen by GRC chairs to present their research on the final day of the
GRC.

Public health relevance
Project Narrative Fungal toxins (mycotoxins) and algal toxins (phycotoxins) are major sources of food-borne and water-borne intoxications to humans, agricultural animals, domestic pets and wildlife. Safeguarding the public requires an understanding of their sources (especially increasing prevalence in the environment), and their chemistry and toxicology. The Gordon Research Conference on Mycotoxins and Phycotoxins provides an international, interdisciplinary forum for the cross-cutting discussion of emerging research on these biotoxins.